Genetic Underpinnings of ipRGC Diversity

PROJECT SUMMARY
Light is a profoundly important regulator of physiology and behavior across a wide range of organisms. Light
information is relayed via diverse retinal ganglion cell types to approximately 50 distinct targets in the brain. The
melanopsin-expressing, intrinsically photosensitive retinal ganglion cells (ipRGCs) represent 6 of the ~40-50
retinal ganglion cell types present in the mouse retina. M1-M6 ipRGCs are defined by a distinct complement of
subtype-defining morphological, physiological, and transcriptional characteristics. However, how this cellular
diversity is achieved is largely unknown. This proposal will investigate the molecular underpinnings of
ipRGC diversity. ipRGCs also represent an excellent microcosm for studying diversity in the larger RGC
population because 1) ipRGCs can be specifically manipulated with multiple, existing genetic tools, 2)
transcriptional profiling has revealed gene expression programs that designate ipRGC subtypes, and 3) the
diversity of ipRGC subtype morphology, physiology, central projections, and roles in behavior are a broad, and
representative subsample of subtype-defining features of RGCs. Thus, ipRGCs are an approachable,
representative, and genetically malleable population in which to study cellular diversity. In the
experiments outlined below, we will exploit the advantages of the ipRGC system by combining targeted, single
cell measurements of ipRGC morphology and physiology with powerful, large-scale transcriptomic approaches
in new genetic models to assess how the full range of ipRGC subtypes are established. Brn3b (Pouf42) is a
transcription factor involved in RGC specification, and its expression is maintained in ipRGC subtypes into adult
stages, where it is poised to influence developmental and adult gene expression programs that give rise to the
subtype-defining properties of ipRGCs. This proposal will test the hypothesis that Brn3b actively shapes
the morphological, physiological, and transcriptional identity of ipRGC subtypes. In Aim 1 we will use new
mouse lines to manipulate Brn3b expression in ipRGCs during development and adulthood to determine the
consequences of increasing or reducing Brn3b levels on the morphophysiological features of ipRGCs. In Aim 2
we will determine the roles of Brn3b in shaping gene expression patterns across retinal development and within
individual ipRGC subtypes. Excitingly, our preliminary data indicate that Brn3b expression levels in ipRGC
subtypes not only correlate with multiple ipRGC features, but also actively regulate defining features of ipRGC
subtypes, suggesting that Brn3b is repurposed throughout development and adulthood to fine-tune ipRGC circuit
structure and function. These studies will generate a blueprint for understanding how the patterning of
transcriptional programs establishes diverse cellular identities in the retina and nervous system.

Public health relevance
PROJECT NARRATIVE The research outlined in this proposal will determine the molecular factors shaping intrinsically photosensitive retinal ganglion cell (ipRGC) subtype identity. ipRGC subtypes differ in their morphological, physiological, and molecular properties, and many of these defining features correlate with expression levels of the transcription factor Brn3b. Therefore, this study will determine how the patterning of Brn3b shapes ipRGC subtype identity. Our findings will provide a blueprint for understanding how transcription factors involved in early specification are repurposed to drive the development of multiple features of cellular structure and function.